How do Cortical regions selective for visual scenes develop in human infants?

Project Summary
The goal of the proposed work is to study the typical development of the critical ability to recognize and navigate the
local visual environment, or ”scene”, which constitutes the bedrock of a healthy, independent, and productive life. A
rich behavioral literature in humans has shown that remarkable spatial and navigational abilities are already develop-
ing within the ﬁrst few years of life. Likewise, extensive neuroimaging work has uncovered a network of brain regions
dedicated to scene perception and navigation in adulthood. However, there is key knowledge gap about how these
regions develop the human brain, particularly during the ﬁrst year of life. Here we propose to study the typical devel-
opment of scene-selective cortex in the awake infant brain using magnetic resonance imaging (fMRI) and functional
near-infrared spectroscopy (fNIRS). Across three aims, we develop and test two competing theoretical frameworks.
One framework suggests that early responses to scenes are driven by low-level visual information inherited from
earlier visual systems, and that higher-level scene responses are built on these foundations via cumulative passive
exposure to visual scenes over time. By contrast, the second framework suggests that early responses to scenes al-
ready reﬂect higher-level information about the navigation-relevant features of scenes, inﬂuenced by connectivity with
regions beyond the visual system, and that representations of the structure of the scene are speciﬁcally enhanced as
infants begin to make independent choices of where to go and how. In Aim 1, we will use fMRI in 2-9 month old infants
to test when responses to scenes depicting navigational affordances ﬁrst emerge in the infant cortex; and whether
connections guiding the development of the network are primarily from earlier visual areas, or also from areas beyond
the visual cortex. In Aim 2, we will use fNIRS and wide-angle immersive displays in 5-11 month old infants to study
whether early-emerging functional responses in this system are driven by low-level features (e.g., peripheral visual
stimulation) only, or also by higher-level information about the functional relevance of scenes (e.g., for navigation).
Finally, in Aim 3, we will quantify infants' ecological passive visual experience with scenes, and how that changes with
motor development, in order to ask whether the onset of independent navigation speciﬁcally shapes the neural devel-
opment of scenes, over and above passive visual experience. The results of this work will yield basic insights into the
typical development of cortical scene processing, and shed light on the fundamental debate in development over the
relative roles of maturation and experience. This work will also inform clinically focused investigations into how the
basic developmental processes studied here go awry in developmental disorders, and hopefully, novel interventions
and rehabilitation strategies for individuals who lose these abilities as a result of stroke or neurodegeneration.

Public health relevance
Project Narrative Humans adults are adept at seeing their way through complex visual environments, relying on cortical regions that respond selectively to visual scenes, but surprisingly little is known about how these cortical regions develop, partic- ularly in the ﬁrst year of life. Here we propose to use neuroimaging in awake infants to test how innate factors and independent navigational experience interact to shape the development of cortical scene processing. This work will help characterize human visual cortical function during its early plastic developmental phase, and provide a critical benchmark for future work on how these systems are disrupted in developmental disorders.